Placental-specific therapy for fetal growth restriction

Project Summary:
Our goal in this competitive renewal of our current award is to develop a therapy that targets the placenta directly,
will be effective in later pregnancy following diagnosis of Fetal Growth Restriction (FGR) and investigate
treatment impact on the fetal, and offspring brain and heart. Development of non-viral, biodegradable, targeted
therapeutics for placental insufficiency could significantly impact infant morbidity and mortality and reduce the
risk of fetal programming leading to metabolic disorder and cardiovascular problems in later life. Polymeric
nanoparticles have passed safety regulations and are already being used in human clinical studies as treatments
for cancers. We utilize a biosynthetic co-polymer, complexed with a plasmid containing the Insulin-like Growth
Factor 1 (IGF-1) gene under the control of trophoblast specific promotors and have successfully shown efficient
nanoparticle uptake into human syncytiotrophoblast ex and in vivo using animal models of FGR (surgically-
induced, genetic manipulation, nutrient restricted). In utero placental therapy challenges current paradigms for
the management of FGR and potentially other pregnancy complications which may benefit from improvement of
the in utero environment, such as preterm birth with sterile inflammation. In addition, our studies will provide
more insight into the mechanisms of fetal programming of the brain and cardiovascular system and the impact
of specific, placenta-only intervention of ameliorating the long-term impacts of being born to small.
The use of placentally-targeted therapeutics is highly innovative, challenging current paradigms for the
management of fetal growth restriction and moving gene therapy beyond imaging, targeting, and destruction of
unwanted cells. The proposed research is significant because development of a placental therapeutic allows
manipulation of the in utero environment and ultimately such capabilities and knowledge has the potential to lead
to the development of the first effective treatment for Fetal Growth Restriction. This application is directly
responsive to two of the topics of special emphasis in the recently re-issued "Notice of Special Interest (NOSI):
High Priority Areas in Placental Research for Healthy Pregnancies" (Reissue) NOT-HD-22-049 including
elucidation of the molecular mechanisms (e.g., transcriptional regulatory pathways and system biology
approaches), involved in the pathophysiology of placental disorders, and development of targeted therapeutic
strategies to prevent and treat pregnancy complications and/or fetal conditions.

Public health relevance
Project Narrative The proposed research is relevant to public health because the development of placental therapies would lead to a treatment for Placental Insufficiency, Fetal Growth Restriction, Preterm birth and a reduced risk of developing adult diseases such as diabetes and cardiovascular disease. Furthermore, this study will elucidate mechanisms of Developmental Origins of Health and Disease and identify if treating the placenta will alleviate sequelae through the lifespan. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to fostering innovative research strategies and their applications as a basis for ultimately protecting and improving health as well as Themes 1, 3, 4 and 5 of the current NICHD strategic plan.